Parental digital location tracking and adolescent substance misuse

PROJECT SUMMARY/ABSTRACT
In the past 5 years, at least 50% of parents in the U.S. have begun using GPS-based location of their teen’s
smartphone (“digital location tracking”) to track where their teen is. Apps like Find My (Apple), Family Link
(Google/Android), or Life360 give parents real-time, on-demand information about where their teen is with
minimal required effort. Because adolescent substance use is strongly linked to location and context, digital
location tracking (DLT) with these apps could be a scalable and effective way for parents to improve their
monitoring of teens and reduce engagement in high-risk drug use and drinking. However, because the
technology only recently became widely accessible, there is minimal published data on how parents use DLT
and what its effects are on teens’ substance use and related behaviors. This project will fill that gap using a
nationwide, longitudinal survey of 430 teen-parent dyads in which the teen has a history of substance use and
the parent uses DLT. In Aim 1, we will characterize when, why, and how parents use DLT (e.g., the frequency,
context, and triggers for checking the app; the information gained; and the actions taken in response). In Aim 2,
we will examine the effects of DLT on a theory-driven array of 8 outcomes, including substance use, using data
from three survey waves spanning 6 months of follow-up. By providing the first detailed descriptive data, the first
longitudinal data, and first comprehensive study of the impacts of DLT, this project will evaluate DLT’s potential
as a scalable and effective way for parents to improve monitoring of teens and reduce high-risk drug use and
drinking. This R21 developmental/exploratory grant will set the stage for a larger-scale longitudinal investigation
of digital location tracking that explores longer-term effects and evaluates its role as an augment to family-based
treatment of teens presenting with substance misuse.

Public health relevance
PROJECT NARRATIVE This project investigates how parents can use digital location tracking (DLT) - the use of smartphone-based GPS to track teens’ location - to deter teens from using alcohol and drugs. We will conduct the first longitudinal and nationwide survey of DLT and first detailed study of its effects. Because DLT is low-burden and requires minimal training to use, it could comprise a scalable and impactful technique to help parents monitor teens better and reduce the acute and long-term consequences of substance involvement.